Research Education Core

PROJECT SUMMARY
The UMass Boston Dana-Farber/Harvard Cancer Center Partnership’s Research Education Core (REC) aims to bridge the divide that exists in the biomedical workforce by increasing the number of UMass Boston students to pursue graduate degrees and cancer research careers. Utilizing evidence-based training that fosters the growth and persistence of students in the sciences, the REC provides trainees with science enrichment education and mentored research experiences which emphasize professional development, research support, and team science across multiple disciplines. The framework of the REC focuses on three areas that are critical to the development of research scientists: (1) acquisition of scientific knowledge; (2) development of communication skills; and (3) individualized career development. The Core will provide four research education programs: undergraduate, post-baccalaureate, graduate, and post-doctoral. Over the course of the grant cycle the REC seeks to support 60 undergraduates (15-20 per year, minimum one semester or summer, 90% multi-semester), 30 graduate students (6-8 per year, most multi-semester), 15 post-baccalaureate students (3 per year for 1-2 years), and 2 nursing post-doctoral scientists (1 per two-year fellowship) in innovative research education programming. Partnership faculty will mentor trainees and fellows at all levels. Recognizing that the needs of individuals vary and that they change at each educational level, the REC will provide individualized and developmentally appropriate experiences aimed at preparing students/trainees for the next phase of their academic and research careers. The REC will continue to provide research opportunities for students at the intersection between the natural/physical sciences and social/behavioral sciences. Over the past 15 years, the Research Education Core (REC) has provided 347 trainees/fellows across the scientific preparation levels with mentored research experiences and scholarly, scientific, and professional development that prepares them to pursue advanced degrees & fellowships, and then to become cancer and/or biomedical science researchers. The REC will continue to use innovative methods to assess the extent to which the Partnership research education program is preparing trainees and fellows to successfully pursue a productive cancer research career. The REC will also advance scientific knowledge on effective research education programs through the submission of manuscripts to peer-reviewed publications regarding the impact of Partnership activities on the future of the biomedical workforce and effective strategies for developing research scientists.

Public health relevance
By drawing our trainees from a student population interested in biomedical careers and providing them with a comprehensive set of research and career development experiences that build scientific knowledge, communication skills, and comfort with the community of science, the Research Education Core will effectively prepare trainees for cancer research careers. Trainees will have opportunities to connect with a wide array of research groups, including individual from the Outreach Core, Research Design and Analysis Core, and Genomics Core; the Center for Personalized Cancer Therapy at UMass Boston; the Center for Translational Health Communications Science at the Dana-Farber Cancer Institute; DF/HCC research labs; and UMass Boston cancer research groups.